Understanding and Treating Substance Use Disorder and Comorbid Conditions in Veterans’ Real-Life Settings

Substance use disorders (SUDs) are very common in Veterans, with 1 in 3 Veterans meeting
criteria for a SUD each year. SUDs typically occur in the context of other comorbid conditions,
such as depressive disorders, post-traumatic stress disorder (PTSD), or anxiety disorders. For
Veterans who have comorbid conditions and SUD, treatment outcomes are worse than those who
have SUD only. We propose that the factors leading to poor SUD treatment outcomes in this
population are not adequately understood and, based on preliminary research, vary widely by
individual. We propose to measure SUD and comorbid symptoms multiple times daily in Veterans
with SUD to characterize the connections between SUD and comorbid conditions for each
individual. N = 74 Veterans with SUD will complete personalized 4-week ecological momentary
assessment (EMA) protocols measuring SUD and comorbid symptoms, as well as personalized
items relevant to each Veteran’s presentation. Personalized models will be estimated from each
Veteran’s EMA data using causal discovery analyses. Veterans will be randomized to either
intervention or control groups. The intervention group will receive their personal causal models
along with an hour-long clinical feedback session based on their model. We will also attempt to
integrate the models into any ongoing treatment and deliver follow-up reminders of key insights
from their models to the intervention participants throughout the remainder of the study. Follow-
up measures will assess the impact of receiving this personalized intervention. A subset of N =
24 Veterans who were in the intervention group will be invited to share their feedback on the
acceptability, relevance, and usefulness of the EMA protocol, personal models, and clinical
feedback, as well as thoughts on the factors that support recovery versus problematic substance
use. Specific aims are: 1) to identify the momentary causes of substance use and urges for
Veterans with SUD, both individually and as a group, 2) Examine the clinical impact of receiving
personal causal models of substance use and urges, and 3) Refine the personal causal models
and clinical feedback to improve acceptability and relevance to Veterans. This project will advance
understanding of day-to-day maintenance mechanisms for problematic substance use in
Veterans with SUD. This study will create causal models of substance and comorbid symptoms
at the individual level and test the impact of receiving clinical feedback based on these models.
Aims will be accomplished through a training plan that involves conducting VA clinical trials, using
causal discovery, and using qualitative analyses to leverage feedback from participants.

Public health relevance
An important part of substance use treatment for many people is learning what triggers their substance use and urges, and how they can better manage those triggers. In our study, we will generate a model for each individual that shows likely causal links between their substance use, urges, and comorbid symptoms (e.g., anxiety, depression, and PTSD), and we will examine these models as a group to draw conclusions about common causes for substance use (and recovery) among Veterans with substance use disorders. We will also test whether receiving a personal model and clinical feedback improves substance use disorder and comorbid symptom outcomes. Results will include both patient-reported and statistically-determined causes of substance use for individuals and groups, clinical impact of a personalized model and feedback session, and participant feedback about the relevance of this study and intervention.